Understanding Compartmentalized Leucine Metabolism Downstream of mTORC1 Signaling

Project Summary/Abstract:
The mechanistic target of rapamycin complex 1 (mTORC1) kinase coordinates cell growth and
metabolism, integrating signals from growth factors, nutrients, and stresses. Many diseases, including cancers,
diabetes, and epilepsy, have been associated with aberrations in mTORC1 signaling. Understanding the inputs
for and outputs of mTORC1 signaling is of critical importance in driving innovations in new therapeutic
interventions for these diseases. Recently, it has been appreciated that mTORC1 signaling is important for
compartmentalized amino acid metabolism; this is particularly true with respect to the essential amino acid
leucine. While leucine activates mTORC1 in the cytosol, mTORC1 also regulates leucine metabolism in the
cytosol, mitochondria, and lysosomes. Recent work from our lab has demonstrated a key role for mTORC1
signaling in regulating the efflux of leucine and other essential amino acids from lysosomes as part of the
cellular response to starvation, but how mTORC1 signaling affects leucine levels in the cytosol and
mitochondria, the two other important sites of leucine metabolism in cells, remains unknown. Answering this
question could help to illuminate how mTORC1 rewires amino acid metabolism in response to starvation. We
will determine how mTORC1 signaling affects compartmentalized leucine metabolism through the following
specific aims: 1) optimize methods to measure compartmentalized leucine levels, 2) determine how mTORC1
activity changes leucine levels in the cytosol and mitochondria, and 3) characterize how mTORC1 activity
affects the rate of leucine catabolism. We will use a multidisciplinary approach, drawing on tools including
genetically encoded fluorescent biosensors, organellar metabolomics, and isotope tracing, to systematically
address how mTORC1 signaling affects leucine levels in the cytosol and mitochondria. Our results will be
important for understanding the role of mTORC1 in regulating adaptive responses to starvation, and may
identify previously unappreciated metabolic vulnerabilities in diseases with dysregulated mTORC1 signaling.
The proposed work, which will take place at the MIT Biology Department/Whitehead Institute—
outstanding intellectual environments that are dedicated to scientific training, includes a strong and
comprehensive training plan. This plan emphasizes the development of experimental skills in cutting-edge
biochemical approaches including protein engineering, fluorescence imaging, and metabolomics; critical
thinking abilities; oral and written scientific communication skills; and science education experience.

Public health relevance
Project Narrative The mTORC1 pathway, which acts as a master regulator of cellular growth and metabolism, is dysregulated in many human cancers. This work seeks to determine how mTORC1 signaling affects compartmentalized leucine metabolism, which is important in how cells respond to starvation. Our work will elucidate how mTORC1 coordinates adaptive responses to starvation, which may reveal novel metabolic vulnerabilities that can be targeted in cancers.